OTUB1 as a Novel Therapeutic Target in Kidney Cancer by Deubiquitinating HIF2alpha

Project Summary Kidney cancer incidence has been increasing steadily for the past several decades, although the reasons for this are unclear. The VHL tumor suppressor gene was identified as a germline mutation in patients at risk for clear cell renal cell carcinoma (ccRCC), which accounts for approximately 85% of all kidney cancers. More importantly, inactivating VHL mutations also play major roles in sporadic renal cell cancer. Work from many laboratories show that the pVHL- associated complex has E3 ubiquitin ligase activity and VHL loss leads to hypoxia inducible factor α (HIF-α, including HIF1α and HIF2α) accumulation. While HIF1α serves mainly as a tumor suppressor in kidney cancer, HIF2α stabilization, as a result of pVHL loss, is sufficient and necessary for promoting kidney tumor growth. Therefore, HIF2α serves as an important therapeutic target in kidney cancer related to VHL loss. While HIF2α can undergo ubiquitination and degradation mediated by pVHL E3 ligase complex, it remains unclear whether HIF2α can also be regulated by deubiquitination pathways. Recently, we performed a deubiquitinase (DUB) siRNA screening (including all of known 96 DUB family members) in kidney cancer cells and identified OTUB1 as a specific deubiquitinase that regulate HIF2α protein levels in kidney cancer. We hypothesize that OTUB1 can serve as a novel therapeutic target in kidney cancer by deubiquitinating HIF2α. In specific aim 1, we will determine the mechanism by which OTUB1 regulates HIF2α protein stability in kidney cancer. In specific aim 2, we will determine the functional role of OTUB1 in kidney cancer in vitro and in vivo. Successful completion of this proposal will motivate the development of specific OTUB1 inhibitors that benefit kidney cancer patients.

Public health relevance
Project Narrative This R21 project's expected outcomes will be the identification and characterization of the potential HIF2α DUB called OTUB1 that may elucidate novel signaling pathways for therapeutic potential. Functional characterization of OTUB1 and its role in regulating HIF2α protein levels in kidney cancer may help us identify new drug targets for kidney cancer and shed light on novel therapeutic modalities to treat this cancer.